Tactile modulation of the neonatal hypothalamus

PROJECT SUMMARY- Social touch contributes to brain and behavior development in the infant attachment
sensitive period. The long-term goal of this project is to understand the sensitive period neural mechanisms of
social touch. We do not yet understand the precise mechanisms by which social touch in infancy is encoded in
the brain. This proposal will help address this need. Oxytocin (OXT) is a candidate touch encoding factor
because of its roles in infant and adult social behavior. Receptors for OXT (OXTR) are expressed in the
developing brain in touch circuits, as well as in a subset of peripheral sensory neurons. Sensory experience
increases infant OXT production in the paraventricular nucleus (PVN) and social touch increases the release of
OXT. Pre-weaning OXTR KO mice have blunted OXT production and blunted PVN activity. Mice with OXTR
deletion from peripheral sensory neurons have impaired social behavior and increased aggression as adults.
These data are consistent with a hypothesis that OXTR on peripheral sensory neurons enhances the touch-
dependent development of the PVN OXT system with lifelong implications for species-typical social behavior.
The experiments in this proposal will test the novel hypothesis that OXTR on peripheral sensory neurons refine
the PVN through social touch dependent activity. Using bulk and cell-type specific transcriptomics and circuit-
based activity, we will determine the role that peripheral sensory OXTR activity has on the development of the
hypothalamus. All of the proposed experiments will be performed in infant mice and the potential for sex
differences will be explicitly tested. Even if our organizing hypothesis is not supported, the data generated will
add new knowledge regarding the impact of touch on hypothalamus development in this sensitive period. The
knowledge gained by these experiments will be informative to improve prevention and intervention during
experience-dependent infant attachment.

Public health relevance
NARRATIVE Social touch during infancy plays a significant role in brain and behavior development and is a life-saving intervention for at-risk newborns. Using developmentally appropriate mouse models, the experiments in this proposal will test a novel mechanism that may influence how social touch is detected by the infant and how it changes brain development at the molecular and cellular level. Identifying the neural mechanisms of social touch is important to improve prevention and intervention during this vulnerable developmental stage.